Cell Culture Core

Core B is the central cell culture facility, which provides support for each of the three projects. The cell culture Core will perform the following functions and services: 1) isolate and culture alveolar and bone marrow-derived macrophages from wild type and genetically modified mice; 2) isolate and culture macrophages from human bronchoalveolar fluid; 3) isolate monocytes from human pheripheral blood; 4) Maintenance and propagation of primary human lung microvessel endothelial cells; 5) isolate, culture, and characterize lung endothelial cells from wild type and genetically modified mice; 6) isolate, culture, and characterize lung epithelial (Type I and Type II) cells from wild type and genetically modified mice; and 7) provide technical support for gene transcription regulation studies. Core B will supply alveolar and bone marrow- derived macrophages from wild type and knockout (Trpm2−/−, Nox2−/−, Nox4−/−, Cd38−/−, Trpm2Mye−/−, Nlrp3−/−, and caspase1−/−) mice, and human alveolar macrophages for the accomplishment of studies proposed in Project 1. For Project 2 studies, Core B will provide mouse lung endothelial and Type II epithelial cells, and supply human epithelial cells. In addition, Core B will also provide for studies in Project 2 bone marrow-derived macrophages from WT, Sphk2−/−, Par−/−, and Creb1Mye−/− mice. For studies proposed in Project 3, Core B will provide human monocytes and lung endothelial cells, lung endothelial cells from WT and Jag1iΔEC mice, and alveolar and bone marrow-derived macrophages from wild type and knockout (Jag1iΔEC, Notch1ΔMye, Notch2ΔMye, and Notch1-Notch2ΔMye) mice. Additionally, Core B will provide technical support for analysis of gene transcription studies proposed in Projects 2 and 3. This Core is essential for the success of the Program Project.